Adapting a Network-Oriented HIV Prevention Intervention for Rural People Who Inject Drugs (PWID)

Project Summary
Recent HIV outbreaks among rural people who inject drugs (PWID) highlighted significant gaps in HIV prevention
science. HIV risk behaviors among PWID are influenced by several factors, including access to sterile injection
equipment and pre-exposure prophylaxis (PrEP), law enforcement practices, and utilization of medications for
opioid use disorder (MOUD) and harm reduction (e.g., accessing syringe services programs [SSPs]). None of
the existing HIV prevention literature has examined the relationships between complex patterns of interactions
and engagements among a triad of HIV risk modifiers (MOUD, harm reduction, and law enforcement), high-risk
behaviors, and HIV incidence among rural PWID during periods of peak HIV transmission. Social network
characteristics are another driver of HIV transmission as PWID networks may be characterized as having specific
norms surrounding injection practices and risk reduction strategies. Studying how combinations of factors known
to influence HIV risks interact at the individual- and network-levels among PWID in rural communities with HIV
outbreaks presents a unique opportunity to inform the design of interventions that can respond to rapidly evolving
HIV prevention needs and barriers. Evidence generated from urban studies documents that network-oriented
interventions focused on social influence processes are able to shift norms related to high-risk sexual behaviors
and injection practices and use of risk reduction strategies, leading to reductions in HIV risk behaviors and HIV
transmission. However, there is limited literature describing how to adapt network-oriented HIV prevention
interventions for rural PWID. To address these gaps, our study aims: 1. To examine longitudinal changes in the
associations between the frequency and types of engagements with a triad of HIV risk modifiers (i.e., MOUD,
harm reduction, and law enforcement), HIV risk behaviors, and HIV incidence among a cohort of rural PWID
(N=400) during a HIV outbreak over 18 months; 2.To examine how the associations between egocentric network
characteristics (e.g., perceived norms, turnover, density) and utilization of three evidence-based approaches to
HIV risk reduction (MOUD, PrEP, and SSPs) change over 18 months among a cohort of rural PWID during a
HIV outbreak; 3. To engage rural PWID in the adaptation and pilot testing of a network-oriented intervention to
reduce high-risk injection practices and sexual behaviors; and 3A. To conduct a pilot randomized controlled trial
(RCT) of the adapted intervention among rural PWID (N=60) to assess acceptability and feasibility. The proposed
research is directly responsive to the 2022-2026 NIDA Strategic Plan. Aims 1 and 2 map directly to Goal 2.2,
“Accelerate the science of harm reduction.” Additionally, this study aligns with Priority Scientific Area #3:
Accelerate Research on the Intersection of Substance Use and HIV in that our rural study setting is experiencing
a HIV outbreak driven in part by social norms surrounding high-risk behaviors and stimulant use. The results of
this study will shift paradigms in how we understand HIV prevention in rural contexts.

Public health relevance
NARRATIVE This study will enhance our understanding of the utilization of multiple evidence-based approaches for HIV risk reduction among rural people who inject drugs (PWID) and afford new insights about how to best meet HIV prevention needs. Our study will fill an important gap in the scientific literature as we will examine how complex patterns of initiation and sustained utilization of multiple risk reduction strategies are associated with network characteristics and change over time. This study will inform the adaptation of an evidence-based intervention for reducing HIV risks among PWID to a rural context.